Tissue Culture and Molecular core

Project Summary (Tissue Culture/Molecular)
Continuing funds are requested by 18 vision scientists (holding 20 eligible NEI R01 grants) and their
personnel to support three resource cores and an administrative core in the merged Department of
Ophthalmology, Visual and Anatomical Sciences (former Ophthalmology and Anatomy/Cell Biology (two)
Departments). The Tissue Culture/Molecular (TC/M) core will be directed by Dr. Jena Steinle, an R01-funded
investigator with significant expertise in tissue culture and molecular biology techniques. Together with the PI,
and a research assistant, the environment and capability to conduct vision research at Wayne State University
and affiliated institutions will be enhanced through prioritization of the work of NEI R01 funded investigators,
their staff and students (graduate and fellows) in numerous aspects of both tissue culture and molecular
biology. The TC/M core will provide vision scientists (priority for NEI R01 funded) with facilities and technical
assistance that will assure quality and cost effectiveness of the work performed. This core will maintain and
propagate ocular and other cell types, as well as provide investigators with genotyping, reverse transcription-
polymerase chain reaction (RT) and quantitative polymerase chain reaction (q)-PCR, gene silencing-siRNA,
shRNA, CRISPR/Cas9, nested PCR and adherence assays. It will also provide for consultation on
recombinant (r) AAV virus vector use (at no cost) and advice to the PI, students or staff for in vitro functional
assessments. Overall, the TC/M core will assist NEI R01-funded investigators and their staff/students in
studies that require the use of tissue culture and molecular biology techniques; foster collaboration between
vision scientists using tissue culture and molecular biological techniques; and bring new investigators into
vision research by providing assistance in tissue culture and molecular techniques that will expand their
research focus.